Development of diagnostic and prognostic ultrasound imaging biomarkers for plantar heel pain

Project Summary/Abstract
Myofascial pain remains an underdiagnosed contributor to a range of musculoskeletal pain conditions. The
lack of validated biomarkers limits the ability to objectively detect myofascial pain, probe underlying pain
mechanisms, and guide targeted treatments. This proposal will address this gap by quantifying the
biochemical, biomechanical, and structural properties of myofascial pain using advanced, quantitative imaging
techniques. As a model of myofascial pain, we have chosen plantar fasciitis, which affects 1 out of every 10
adults. Our long-term goal is to enhance musculoskeletal pain management by creating better tools for
detecting abnormal myofascial tissue that enable more individualized treatment.
The objective of the R61 phase is to use novel imaging techniques to develop a diagnostic biosignature to
objectively and accurately determine the location and severity of abnormal myofascial tissue. Our approach will
use a cross-sectional study design with 3 groups: plantar fasciitis (n=50), Achilles tendinopathy (n=25), and
pain-free controls (n=25) to test Specific Aim 1: Develop a diagnostic imaging biosignature of myofascial
tissue to differentiate individuals with plantar fasciitis from other foot pain without a myofascial
component (Achilles tendinopathy) and from matched pain-free controls.
The objective of the R33 phase is to use novel imaging techniques to develop a predictive biosignature to
identify individuals most likely to respond to DN, and a response biosignature to guide dosing or continued use
of DN for myofascial pain for individuals with plantar foot pain. Our approach will use a parallel-group, doubleblinded randomized controlled trial (RCT) design with imaging measured before, during (1 m.), and after
treatment (3 & 6 m.). Participants will be randomized to one of two groups: 1) DN + standard care, or 2) Sham
DN + standard care to test Specific Aim 2: Determine 2A) predictive (Independent variable: imaging
biosignature; Primary outcome: Pain Intensity) and 2B) response (Independent variable: DN vs. Sham DN;
Primary outcome: Imaging biosignature/biomarkers) imaging biosignatures in an RCT.
Exploratory Aim 3: Will develop composite biosignatures, that combine multiple imaging biomarkers
developed in Aims 1 or 2 with psychosocial factors, to enhance the diagnostic, predictive, or response
capability for myofascial pain.
Transition criteria. 1) Adequate recruitment with >90% of participants in each group enrolled; 2) Adequate
representation with neither sex exceeding 60% of the sample; 3) Minimal missing data (<5%) for collected
outcomes; 4) At least 2 diagnostic imaging biomarkers with an ROC AUC > 0.7 and FDRs < 0.1; 5-8) Submit
DSMP, Study Accrual and Retention Plan, Final sample size and statistical analysis informed by mock
recruitment, and R33 transition application, including implementation of an effective sham DN.

Public health relevance
Project Narrative This research addresses the pressing issue of underdiagnosed myofascial pain, which plays a significant role in various musculoskeletal pain conditions, including plantar fasciitis. By developing novel imaging biomarkers, this study aims to provide objective means of detecting myofascial pain, understanding its underlying mechanisms, and guiding personalized treatments. Given the high prevalence of plantar fasciitis and its long-lasting impact, this research has the potential to improve the diagnosis and treatment of not only this condition but also other lower extremity musculoskeletal disorders, ultimately enhancing public health by reducing illness and disability associated with chronic pain.